Neuroinflammatory Status as a Driver of Pathophysiology Following Repetitive Traumatic Brain Injury

Traumatic Brain Injury (TBI) is caused by a mechanical insult to the head and often results in prolonged or
permanent brain dysfunction. TBI represents a major health and socioeconomic problem; in the U.S. over 2.8
million are affected annually. Even so-called “mild” TBI – otherwise known as concussion – may induce
neurophysiological deficits affecting learning, memory, and concentration that do not resolve in up to 15-20% of
patients. There are currently no approved treatments to improve recovery from TBI. Through previous extensive
neuropathological examinations, we have shown that mild TBI is associated with subtle changes in synaptic loss
or gain and neuronal hypertrophy occurring concomitantly with migration and activation of microglia – the
resident immune cell of the central nervous system. We have also detailed persistent changes to microglia
morphology in distinct white matter and gray matter regions after a single mild TBI. The objective of this proposal
is to establish the function of microglia and the overall neuroinflammatory response in secondary
pathophysiology for a range of TBI severities, with a particular focus on the role of hyper-ramified microglia on
responses to repeat TBI. To accomplish these objectives, we will utilize our porcine model of closed-head
rotational-acceleration-induced TBI, which closely replicates human head injury biomechanics that cannot be
reproduced in small animals. In Aim 1, we will characterize the effect of mild or moderate injury severity on TBI
pathology through transcriptomic profiling and immunohistochemical protein expression. In particular, RNA
sequencing will be performed to examine neurodegenerative and neuroinflammatory pathways followed by
immunohistochemistry to provide regional context to neuronal loss and immune cell activation, amongst other
pathologies. In Aim 2, animals will perform a battery of neurobehavioral tasks to assess spatial memory and
working memory. We will then create a statistical model to correlate the extent of behavioral and cognitive deficits
with transcriptomic and neuropathological changes post-TBI. Finally, in Aim 3, we will test the effect of repeat
TBI on neuroinflammatory states. We will subject pigs to a second TBI at either a timepoint shown to present
maximal elevations in hyper-ramified microglia or a timepoint where the density of this microglial phenotype has
returned to baseline. Changes in gene expression, neuropathology, and behavior will be assessed. Our
hypothesis is that repeat TBI during a period with elevated levels of hyper-ramified microglia will result in
excessive synaptic pruning/loss, exacerbated neuronal hypertrophy, and elevated deficits in hippocampal-
dependent cognitive tasks. Across these aims, we will use established methodologies to generate
comprehensive genomic, pathological, and cognitive profiling of clinically relevant TBI and create open access
datasets that other TBI researchers can interrogate against rodent and human model systems. Overall, the
current proposal is a critical step in identifying inflammation-related degenerative pathology that may underlie
the cognitive, behavioral, and motor dysfunction that millions of Americans experience as a result of TBI.

Public health relevance
This proposal will investigate the role of neuroinflammation as a driver of neuropathology following repeat traumatic brain injury (TBI) – which affects over 2.8 million people in the U.S. each year – as we will measure inflammation-related genomic, cellular, and behavioral changes and correlate these to neuropathological consequences using a unique swine model of clinically relevant TBI. First, we will ascertain the underlying genetic and molecular factors contributing to post-TBI neuroinflammation following mild or moderate TBI, followed by a study correlating the extent of behavioral and cognitive deficits with these genetic and molecular changes. Finally, we will test the effect of repeat TBI on genomic, cellular, and behavioral changes during and after a period of neuroinflammation triggered by an initial TBI. This work will guide future studies by comprehensively characterizing genomic, pathological, and cognitive changes after clinically relevant TBI and establish susceptibility to deficiencies in neuronal and neurocognitive health following repeat TBI.